Prognostic implications of mitochondrial inheritance in myelodysplastic syndromes after stem-cell transplantation

ABSTRACT
No change with parent grant.
Myelodysplastic syndromes (MDS) are a heterogenous group of clonal hematopoietic stem cell disorders,
characterized by ineffective hematopoiesis and a tendency to progress to acute myeloid leukemia in 30% of
the patients. Currently the only curative therapy for MDS is allogeneic hematopoietic stem-cell transplantation
(HCT). However, the mortality after HCT is high due to relapsed disease and transplant-related complications.
The commonly used MDS prognostic models for HCT only consider non-genetic factors, thus could not
accurately predict the outcomes after HCT. Novel predictive markers are therefore critically needed to identify
patients who are most likely to benefit from HCT. Mitochondria play a critical role in hematopoietic cell
homeostasis and differentiation. Genetic and epigenetic alterations in mitochondrial DNA (mtDNA) can impair
mitochondrial functions and play a pathophysiological role in MDS. This Career Development Award will
provide training and research experience to Dr. Dong to support her long-term career goal of becoming an
independent investigator in integrative molecular epidemiology, with a focus on applying state-of-the-art omics
technologies and innovative population-based epidemiologic methods to reduce the burden of hematologic
malignancies. While Dr. Dong has had comprehensive training in genetics and epidemiology, she requires
further training in methodologies of HCT-related outcomes and epigenetics. She has assembled a mentoring
team comprised of a primary mentor, Dr. Raul Urrutia, Director in the Genomic Sciences and Precision
Medicine Center and renowned leader in genomics, epigenomics and precise medicine; and two co-mentors:
Dr. Wael Saber, Professor and Scientific Director in the Acute and Chronic Leukemia Working Committees in
the CIBMTR specializing in HCT and MDS; Dr. Paul Auer, Professor and Cancer Center Core Director with
expertise in statistics and bioinformatics. Leveraging the existing whole genome sequencing data from the
“MDS Genomics and Epigenetics Study” in the CIBMTR, Dr. Dong will focus on mitochondrial genome to
address the research gaps mentioned above: 1) determine mitochondrial genomic landscape associated with
MDS outcomes after allo-HCT; 2) quantify mtDNA copy number and evaluate its associations with MDS
outcomes after HCT; and 3) identify mtDNA methylation profiles associated with MDS outcomes after HCT.
The findings will improve our understanding of MDS etiology and provide additional molecular predictors of
MDS outcomes after HCT to help developing individualized risk prediction and targeted treatments.

Public health relevance
PROJECT NARRATIVE No change with parent grant. Identification of mtDNA alterations prognostic of MDS after HCT will improve our understanding of the etiology of MDS, help developing individualized risk stratification and improving the outcomes for patients with poor HCT prognostic features.